Parallelization and Interactive Documentation to Maximize the Accessibility of Harmony

PROJECT SUMMARY
As the availability of large datasets in biomedicine continues to grow, researchers face the challenge of
integrating these datasets to unlock their full potential. However, combining datasets is challenging due to
technical confounders, also known as batch effects. Batch effects can emerge in all domains of science and
engineering, so the need to correct for technical artefacts is widespread. The Harmony algorithm was originally
developed to address correct for batch effects in single cell RNAseq (scRNAseq) data, enabling robust,
scalable integration of diverse datasets. Its speed, accuracy, and usability have led to its adoption in platforms
like Seurat and ScanPy, with over 5,000 citations and 195,000 CRAN downloads. However, as datasets
surpass 100 million cells and new technologies generate even larger datasets, significant updates are needed
to scale Harmony for modern use cases, such as multimodal and spatial transcriptomics (ST) data integration.
Scaling Harmony requires moving beyond single-core implementations. Parallelization is feasible due to
Harmony's modular nature and reliance on matrix operations. In Aim 1 we will Refactor Harmony to scale to
1 billion cells through parallelization using two strategies, multicore parallelization and GPU
implementation. The first strategy will allow us to take advantage of multiple cores to achieve a speed-up
proportional to the number of available units. For the second approach we will implement GPU support using
MAGMA to maximize performance on various hardware configurations, and we expect run times to be sped up
by 1-2 orders of magnitude. In Aim 2 we will Interactive web-based documentation for Harmony best
practices for both existing and emerging use cases. In our first subaim we will focus on addressing issues that
are most commonly encountered by users. In the second subaim we will expand the documentation and the
vignettes to cover more advanced use cases. Although Harmony was initially designed for integrating
scRNAseq data, the model has proven to be generalizable and the software has been used in many other
contexts. Here, we propose to carry out extensive testing for some of these use cases to establish best
practices that can be communicated to users. Specific focus will be on the integration of spatial transcriptomics
datasets with scRNAseq data. This resource will be made freely available as an interactive guide for
troubleshooting batch integration issues. The improvements proposed here will enable researchers to integrate
large, complex datasets across diverse modalities, maximizing the impact of Harmony in single-cell genomics
and beyond. With a strong track record in algorithm development, benchmarking, and education, our team is
well-positioned to implement these enhancements, ensuring Harmony remains accessible and efficient for the
growing community of users.

Public health relevance
PROJECT NARRATIVE We will develop multithreading and GPU support for the Harmony batch integration method, allowing efficient scaling up to 1 billion cells. Furthermore, we will develop extensive, interactive documentation to facilitate troubleshooting for users of different skill levels. Importantly, this includes establishing best practices for use cases such as spatial transcriptomics and multi-omics integration that the method was not originally designed for, but nevertheless has already proven to be highly useful.